Explainable and Ethical AI for Studying Alzheimer's Disease

Alzheimer's Disease (AD) is increasingly becoming an immense economic and social challenge. By 2050, it's
projected that 13.8 million Americans will be living with AD, and the total annual expenditures for health, long-
term care, and hospice services for those with AD and other dementias could surge to $1.2 trillion. Developing
predictive artificial intelligent (AI) models to assist in the diagnosis and prognosis of the disease is critically
important for patient management. However, current AI models for studying Alzheimer’s Disease often suffer
from explainability challenges, and the effects of race, sex, social determinant of health (SDOH), and
comorbidity are typically not considered in existing research but are critically important to consider for creating
ethical AI models. Building on our team’s pioneering work in explainable AI, studying the role of race, SDOH,
comorbidity in AD, and leveraging cerebrospinal fluid (CSF) proteomics for studying AD, we will develop
explainable and ethical AI models for both automated disease diagnoses and prognosis. We will build AI
models for multimodal data-fusion and leverage our pioneering work in CSF proteomics to understand
covariation patterns between brain volumetrics and connectome, amyloid and tau depositions, and CSF
proteins with a goal to enhance our understanding of AD pathophysiology. Successful completion of this study
will provide improved and ethical AI models that can be further developed into effective clinical decision
support tools as well as enhance our understanding of the pathophysiology of AD.

Public health relevance
Project Narrative Alzheimer's Disease (AD) is rapidly transforming into a significant economic and social challenge. This proposal will develop and apply advanced AI models to study Alzheimer’s Disease, including the effects of race, comorbidity, and social determinant of health on Alzheimer’s Disease as well as identifying cerebrospinal fluid proteins that are predictive of cognitive decline. Successful completion of this study will provide improved and fair AI models that can be further developed into effective clinical decision support tools as well as enhance our understanding of the pathophysiology of AD.